Computational Methods for Unraveling Combinatorial Gene Regulation

DESCRIPTION (provided by applicant): Combinatorial regulation of gene expression by multiple transcription factors (TFs) is a fundamental mechanism for regulating gene expression. Although this phenomenon has been studied for several decades, we still lack a systematic strategy to accurately identify combinatorial TF interactions at enhancers and to model their regulatory output on target gene(s), especially for mammalian species. If successful, the proposed research will remove a bottleneck in the field and represent the first step in a continuum of research that is expected to further our understanding of gene regulation. Research proposed in this application is innovative, in our opinion, because it represents a new and substantive departure from the status quo. We will address the following three challenges facing researchers in the field: 1) lack of strategies to identify combinatorial interactions among TFs at enhancers; 2) lack of strategies to associate enhancers with their target genes; and 3) limited ability to translate enhancer sequence information to its regulatory output. At the completion of this project, we expect to have developed a set of computational methods that enable genome-scale identification of combinatorial interactions at enhancers and construction of predictive models of combinatorial regulation in mammals. In addition, by applying our methods to large public datasets, we expect to obtain new insights into the evolutionary, spatial, and temporal dynamics of enhancers. The computational methods developed will be implemented as open-source software and made publicly available to the research community.

Public health relevance
PUBLIC HEALTH RELEVANCE: Many human diseases are caused by dysregulated gene expression. Combinatorial action by multiple transcription factors is critical to gene regulation. better understanding of this regulatory mechanism is essential for understanding and treatment of human diseases.